Microneedle-based mRNA Flu Vaccine for Transcutaneous Immunization

Flu is a contagious respiratory disease caused by influenza viruses, which infect the nose, throat, and sometimes
the lung. It can cause mild to severe illness and at times lead to death. The best way to prevent seasonal flu is
by receiving a flu vaccine annually. Multivalent flu vaccines are designed to protect against the 3-4 influenza
viruses that research predicts would be most common during the upcoming flu season, and due in part to having
to guess next season’s strains, the CDC reported effectiveness of seasonal flu vaccine in the U.S. ranged
between 19% and 60% over the past 15 years. For a flu pandemic that occurs occasionally, a new vaccine would
be needed. Our long-term goal is to develop a universal influenza vaccine. A stable, microneedle-based,
multivalent messenger RNA (mRNA) flu vaccine that allows non-invasive, patient-friendly intradermal
administration would be an ideal candidate of such a vaccine, as there are many antigen-presenting cells in the
dermis, and often a significantly lower dose of vaccine is needed when a vaccine is given intradermally as
compared to the intramuscular injection. Our objective in this phase 1 STTR application is to develop a
microneedle-based influenza virus hemagglutinin (HA) mRNA vaccine candidate by taking advantage of our
proprietary thin-film freeze-drying technology and to evaluate the HA-specific immune responses induced in a
mouse model. Our hypothesis is that transcutaneous immunization using HA-encoding mRNA-lipid nanoparticle
(LNP)-carrying microneedles will induce strong specific humoral and cellular immune responses. To date, we
have developed a prototype HA mRNA-LNP-carrying microneedle system. We have shown that the mRNA-LNPs
released from the microneedles maintained their physicochemical properties as well as the mRNA encapsulation
efficiency, and importantly the microneedles can successfully deliver the mRNA-LNPs into the pores created in
mouse skin by applying the microneedles. To accomplish our objective and to test our hypothesis, we propose
the following two specific aims: (1) to optimize the process of manufacturing the HA mRNA-LNP-carrying
microneedles, and (2) to evaluate the immune responses induced by the HA mRNA-LNPs in mice that are
transcutaneously immunized into the skin with the microneedles. To safeguard the success of the proposed
project, we have assembled a team with extensive experience in microneedle-based immunization, mRNA
vaccine, and vaccine development. Upon the completion of this phase 1 project, we expect to have optimized
the mRNA-LNP-carrying microneedle manufacturing process and validated the immunogenicity of the mRNA-
carrying microneedles in a mouse model for a phase 2 application to further optimize the design of the mRNA-
LNP-carrying microneedles, scale up their manufacturing process, and test their safety and effectiveness in
mouse and ferret models. Such an outcome would be highly impactful for the ultimate development of a stable,
microneedle-based universal mRNA flu vaccine.

Public health relevance
The proposed research is relevant to public health because we aim at developing a stable influenza virus mRNA vaccine candidate for non-invasive transcutaneous immunization. Therefore, the proposed research is relevant to the NIH’s mission of enhancing health, lengthening life, and reducing illness and disability.